Targeting Oncostatin M-Receptor to Suppress Metastasis and Therapy Failure

ABSTRACT
The metastatic spread of cancer cells and recurrence are intimately linked to therapy failure, which remains an
important clinical challenge for patients with metastatic Triple Negative Breast Cancer (TNBC). Two important
factors that regulate TNBC metastasis and recurrence are: (i) the differentiation status of the cancer cells, and
(ii) the functionality of the immune system within the
tumor microenvironment (TME). Both the cancer cells and
the immune cells are highly influenced by the cytokines Oncostatin M (OSM) and Interferon-beta (IFNB). We find
that the actions of OSM and IFNB oppose one another in regulating both cancer cell differentiation and immune
system function within the TME. OSM and its receptor (OSMR) are frequently upregulated in aggressive,
metastatic and therapy-resistant recurrent cancers, such as TNBC. Mechanistically, OSM/OSMR elicits robust
activation of STAT3, which forms a transcriptional complex with SMAD3, and induces stem-like/mesenchymal
programs that enhance TNBC aggressiveness and resistance to chemo- and immuno-therapy. Moreover, the
cooperation of STAT3 and SMAD3 on co-dependent gene promoters produces a pro-inflammatory, tumor-
promoting TME by suppressing the production of immune-activating IFNB and inducing immune-inhibitory
cytokines. Restoring IFNB signaling prevents and reverses stem-like/mesenchymal programming stimulated by
OSMR and STAT3/SMAD3. Thus, the cooperation between STAT3 and SMAD3 to inactivate IFNB :STAT1/2
signaling axis represents a key step in metastatic progression and tumor recurrence. Based on these and other
compelling findings, we will test the hypothesis that the relative balance between OSM:STAT3/SMAD3 and
IFNB :STAT1/2 signaling in both TNBC cells and immune cells dictates metastatic relapse and ultimately, patient
outcomes. We’ll test this hypothesis in two Specific Aims: Aim 1 will determine how IFNB suppresses OSMR-
mediated STAT3/SMAD3 co-dependent gene expression; Aim 2 will define how OSMR/ERK signaling activates
STAT3/SMAD3 to drive stem-like/mesenchymal reprogramming and the suppression of IFNB/ISGs. Together,
the results from our studies will provide a greater understanding of the molecular mechanisms by which OSM
and IFNB antagonize one another and test novel therapeutic approaches to shift the balance towards active
IFNB :STAT1/2 and away from OSMR:STAT3/SMAD3 in both TNBC and immune cells, with the goal of improving
outcomes for patients with metastatic TNBC.

Public health relevance
PROJECT NARRATIVE Stem-like cancer cells are the “roots” of aggressive tumors, as they seed metastasis and recurrence; devising a way to kill this population of cells or prevent them from being generated remains a significant clinical challenge. We identified Oncostatin M as a key driver and maintenance factor for these stem-like cells and as a suppressor of the immune system. Here, we’ll define novel signaling effectors activated by the Oncostatin M Receptor, providing us with an extraordinary opportunity to develop combination therapies aimed at suppressing the generation and maintenance of invasive, drug tolerant cancer cells and activating the immune system to improve current therapies.